BLRD Research Career Scientist Award Application

Abstract
Alcohol use disorder is one of the major health concerns for veterans, as well as for the general
population. An integral part of the mission of the VA is to provide care for VA patients suffering
from alcohol and/or drug abuse problems with and without comorbid anxiety. The overall aim of
Dr. Pandey’s research program is to elucidate the epigenetic mechanisms that underlie the
pathophysiology of alcohol use disorder (AUD) and co-morbid anxiety disorders. Numerous
studies performed by Dr. Pandey’s laboratory have found that ethanol exposure results in
epigenetic alterations involving histone acetylation/methylation, DNA methylation, and non-
coding RNAs that modulate gene expression in the amygdala. The major focus of his
laboratory is the role of these epigenetic mechanisms and non-coding RNAs in
transcriptomic changes in specific neural circuitries, particularly in the amygdala, and
the subsequent induction of behavioral phenotypes that underlie ethanol withdrawal-
induced anxiety and the co-morbidity of anxiety and AUD. His lab investigates the
differential epigenetic effects of acute and chronic alcohol exposure and withdrawal in both
early-life and adult animal models, as well as in adult animals that were exposed to alcohol in
adolescence. These findings are then translated to humans using postmortem brains of
individuals with AUD and control subjects. In addition to his own laboratory’s research, Dr.
Pandey has programmed several events for the educational enrichment of next-
generation and current researchers in the field and is involved in many collaborative
studies with VA and UIC researchers. Taken together, these research projects are shaping
the field’s understanding of AUD and will inform the development of novel pharmacological
interventions for the treatment of AUD, with and without comorbid anxiety, in veterans and in the
general population.

Public health relevance
Project Narrative Veterans suffering from post-traumatic stress disorder (PTSD) experience high anxiety levels, which increases their susceptibility to alcohol and drug addiction. As a result, alcohol use disorder (AUD) is one of the major health concerns for veterans. This research program will elucidate various epigenetic mechanisms in brain circuitry associated with the development of alcohol addiction in concert with anxiety-like behaviors. This research will inform the development of novel pharmacological therapies that target these molecular pathways in order to treat AUD, both with and without comorbid anxiety.